EFFICACY OF CHELATION THERAPY FOR LEAD INTOXICATION IN CHILDREN

Three forms of inpatient chelation are being utilized in the treatment of children with elevated blood lead levels, and their efficacy will be carefully studied.